Tracking the flow of malaria parasites and drug resistance within the DRC and across its borders

ABSTRACT Malaria? ?remains? ?endemic? ?in? ?sub-Saharan? ?Africa? ?in? ?large? ?part? ?due? ?to? ?continued? ?evolution? ?and? ?spread? ?of? ?drug resistance? ?which? ?undermines? ?ongoing? ?large-scale? ?control? ?and? ?elimination? ?efforts.? ?We? ?will? ?leverage high-throughput? ?genotyping? ?of? ?parasites? ?using? ?a? ?state-of-the-art? ?panel? ?of? ?molecular? ?inversion? ?probes? ?(MIPs)? ?for targeted? ?sequencing? ?of? ?thousands? ?of? ?resistance? ?and? ?neutral? ?loci? ?across? ?thousands? ?of? ?infections? ?covering? ?the entire? ?Democratic? ?Republic? ?of? ?Congo? ?(DRC)? ?and? ?select? ?areas? ?in? ?bordering? ?countries.? ?This? ?will? ?provide? ?us? ?a? ?map with? ?an? ?unprecedented? ?scale? ?and? ?resolution? ?to? ?define? ?the? ?evolution? ?and? ?spread? ?of? ?antimalarial? ?resistance mutations.? ?In? ?this? ?project,? ?we? ?will? ?first? ?develop? ?our? ?genotyping? ?panel? ?which? ?should? ?provide? ?a? ?high-resolution? ?tool for? ?studying? ?all? ?known? ?drug? ?resistance? ?loci? ?and? ?general? ?parasite? ?population? ?structure? ?in? ?this? ?and? ?other? ?settings. Applying? ?this? ?to? ?well? ?annotated? ?samples? ?from? ?across? ?the? ?DRC? ?and? ?bordering? ?countries,? ?we? ?will? ?define? ?the prevalence? ?of? ?drug? ?resistance? ?mutations? ?and? ?define? ?them? ?based? ?on? ?their? ?genetic? ?haplotypes? ?which? ?act? ?as? ?a unique? ?fingerprints.? ?We? ?will? ?then? ?map? ?these? ?drug? ?resistance? ?haplotypes? ?and? ?study? ?their? ?spread? ?and? ?spatial associations? ?and? ?further? ?examine? ?their? ?epidemiologic? ?associations? ?and? ?interactions.? ?Onto? ?this? ?detailed? ?spatial map,? ?we? ?will? ?? ?examine? ?specific? ?locales? ?of? ?interest? ?for? ?temporal? ?changes.? ?? ?These? ?focal? ?regions? ?in? ?the? ?DRC represent? ?diverse? ?ecologic? ?and? ?demographic? ?features? ?that? ?likely? ?impact? ?resistance? ?spread? ?and? ?evolution including? ?areas? ?with? ?minimal? ?health? ?care? ?infrastructure? ?and? ?ongoing? ?regions? ?of? ?conflict.? ?Our? ?final? ?work? ?will? ?be? ?to apply? ?more? ?sophisticated? ?models? ?to? ?the? ?rich? ?sequence? ?data? ?in? ?order? ?to? ?estimate? ?the? ?flow? ?of? ?parasites? ?and resistance? ?mutations? ?within? ?and? ?between? ?the? ?DRC.? ?This? ?includes? ?the? ?development? ?of? ?new? ?? ?population? ?structure models? ?(MALECOT)? ?incorporating? ?parasite? ?infections? ?that? ?have? ?multiple? ?strains? ?allowing? ?for? ?a? ?better understanding? ?of? ?the? ?full? ?dataset? ?as? ?in? ?polyclonal? ?infections? ?are? ?often? ?the? ?majority? ?in? ?endemic? ?African? ?countries. This? ?model? ?should? ?be? ?broadly? ?applicable? ?to? ?other? ?studies? ?of? ?malaria? ?or? ?infections? ?with? ?mixed? ?strains.? ?We? ?will also? ?leverage? ?? ?spatially? ?explicit? ?models? ?to? ?define? ?general? ?parasite? ?flow? ?in? ?both? ?relative? ?and? ?absolute? ?terms comparing? ?and? ?contrasting? ?to? ?the? ?flow? ?of? ?resistant? ?parasites.? ?This? ?work? ?will? ?provide? ?the? ?patterns? ?of? ?general? ?gene flow? ?and? ?barriers? ?on? ?the? ?spread? ?of? ?specific? ?drug? ?resistance? ?alleles? ?and? ?haplotypes.? ?In? ?summary,? ?not? ?only? ?will this? ?project? ?enhance? ?our? ?understanding? ?of? ?malaria? ?landscape? ?genetics? ?and? ?the? ?evolution? ?and? ?spread? ?of antimalarial? ?resistance,? ?it? ?will? ?provide? ?tools? ?and? ?analysis? ?framework? ?for? ?improving? ?public? ?health? ?interventions that? ?will? ?directly? ?inform? ?the? ?DRC? ?National? ?Malaria? ?Control? ?Program.

Public health relevance
PROJECT NARRATIVE Falciparum malaria remains a major global public health problem and the continued evolution and spread of drug resistance impedes control efforts in endemic countries such as the Democratic Republic of Congo. To better understand the evolution and spread of drug resistance this project will genotype thousands of malaria infections from across the entire country to define all known resistance genes and determine barriers and corridors of gene flow that can be targeted in public health interventions.